Impact of a Disease-Associated Dynactin Variant on Motile Phenomena in Lung Epithelial Cells

Project Summary
The microtubule-based motor, cytoplasmic dynein-1, is best known for providing motile functions in
membrane trafficking and mitosis. Complete abrogation of dynein function yields gross cellular and
organismal defects that preclude detection of its contributions to other important cellular phenomena. The
work described in this proposal focuses on a human dynein variant, DCTN4Y270C, that is associated with
increased risk of extreme lung pathology. DCTN4Y270C (rs35772018) was first identified as a genetic
modifier of cystic fibrosis but has also been associated with increased risk of lung adenocarcinoma and
acute respiratory distress syndrome following sepsis. Homozygous DCTN4Y270C has no obvious impact on
its own, indicating that any defects associated with DCTN4Y270C exacerbate pathology but do not cause it
directly.
Lung epithelial cells must be able to undergo a reversible epithelial-mesenchyme transition (EMT) to
provide the ongoing wound-healing that is required for repair and maintenance of the airway. Imbalance in
reversible EMT is believed to underlie the fibrosis seen in severe lung disease. Phenotypically, DCTN4Y270C
expression yields reduced cell movement into experimental wounds and facilitates acquisition of epithelial
polarity, both hallmarks of the mesenchyme-epithelial transition (MET). Transcriptionally, cultured
bronchial epithelial cells expressing DCTN4Y270C show with hallmarks characteristic of EMT. These
incongruent findings indicate that DCTN4Y270C positions cells in an aberrant, yet tolerated, state that lies
between epithelia and mesenchyme, similar to the partial EMT seen in tumors. The overarching goal of the
proposed work is to understand how DCTN4Y270C affects lung cell biology, specifically the cytoskeleton-
dependent phenomena that underlie directed cell migration.
To obtain mechanistic insight into how DCTN4Y270C alters cell function we determined the interactomes of
DCTN4WT and DCTN4Y270C using BioID proximity biotinylation. This revealed a small cohort of differential
interactors that others have linked to the phenomena we know to be altered in cells expressing
DCTN4Y270C. The aims of this project are to establish mechanistic connections between dynein/dynactin
and these novel interactors, taking advantage of DCTN4Y270C as a unique tool for modulating and
perturbing cell function.

Public health relevance
Project Narrative The cells that line the human airway are under constant environmental assault and defects in lung tissue repair can be fatal. This project’s relevance stems from an earlier study that identified a non-synonymous variant of DCTN4 (rs35772018; DCTN4Y270C) that was highly associated with worse disease progression in cystic fibrosis and higher likelihood of acute respiratory distress syndrome due to sepsis. The work proposed here will provide a deeply mechanistic understanding of how DCTN4Y270C alters cellular movements that are essential for lung epithelial cell function.